Point-of-Care Metagenomics for Rapid Detection of pathogens and Antimicrobial Resistance in Sight-Threatening Ocular Infections

PROJECT SUMMARY
Timely and accurate diagnosis of ocular infections is critical to guide early effective therapy and save vision.
However, because current methods for diagnosis of ocular infections are time-consuming and not sensitive,
empirical treatment with broad-spectrum therapies selected on the basis of clinical judgment continues to be the
mainstream approach. Since ocular infections are caused by a wide range of organisms, which may present with
overlapping features, many patients are treated unnecessarily with inappropriate antimicrobials. These broad-
spectrum scattershot approaches lead to increased toxicity, select for resistant bacteria, and are increasingly
compromised by the global emergence of antimicrobial resistance (AMR). AMR is a global pandemic that poses
a major threat to vision health, as ocular pathogens are becoming increasingly resistant to first-line antimicrobials
used in ophthalmology. Unlike infections at many other sites, delays in diagnosis and in initiation of targeted
effective treatment of ocular infections can lead to serious consequences. Treatment failures or reduced efficacy
due to AMR can result in delayed infection resolution and consequences ranging from incremental visual loss to
loss of the eye. Metagenomic sequencing-based approaches are increasingly being explored to detect
pathogens and predict their antimicrobial resistances. Recent technological advancements now place the
development of rapid near point-of-care diagnostic tests that employ third-generation sequencers (e.g., Oxford
Nanopore) within reach. Our goal is to capitalize on these advances, and combine them with novel bioinformatic
tools for real time pathogen identification and methods for pathogen enrichment to create a completely
cultureless precision diagnostic tool for improved diagnosis of sight-threatening ocular infections. First, we will
develop and validate a practical metagenomic sequencing approach for rapid, sensitive and comprehensive
detection of bacteria, fungi and acanthamoeba from ocular samples using the portable Nanopore sequencer.
This will be accomplished using specimens derived from ex-vivo models of keratitis and endophthalmitis with
known microbial loads. Clinical validation will be performed using our existing large biorepositories of clinical
specimens collected from patients presenting with sight-threatening keratitis and endophthalmitis and additional
samples to be collected prospectively. Additionally, we will also adopt and validate direct association approaches
for antibiotic resistance prediction using the minimum of new sequence information necessary. At the
conclusion, we will have developed a rapid and culture-independent precision diagnostic approach that would
transform ocular infection diagnosis and treatment from an empirical one-size-fits-all approach to a precise and
more effective one tailored to the patient’s needs. This has the potential to significantly advance clinical
management and help improve the care of patients suffering from sight-threatening infections.

Public health relevance
PROJECT NARRATIVE Bacteria that cause ocular infections are becoming increasingly resistant to antimicrobials used in ophthalmology, leading to recalcitrance to cure and treatment failure that can result in serious morbid consequences such as blindness and loss of the eye. This proposal will combine the latest developments in DNA sequencing, microbial enrichment methods and bioinformatics to develop a precision diagnostic tool able to identify the causative agent of the infection and predict antimicrobial agents to which the organism is resistant in a timely and sensitive manner, supporting the use of targeted and effective therapies at early stages of the disease. This work will ultimately provide an innovative diagnostic test extensively optimized for clinical application that has the potential to significantly advance clinical management and help improve the care of patients suffering from sight-threatening infections.